Brain Research Apprenticeships in New York at Columbia (BRAINYAC)

PROJECT SUMMARY
This renewal proposal seeks to build and strengthen an existing program for high school students to gain
mentored laboratory research experience during the summer, Brain Research Apprenticeships in New York at
Columbia (BRAINYAC). At the end of the current funding period, BRAINYAC will have trained and prepared 94
high school students from low-resourced neighborhoods in New York City for summer research experiences in
neuroscience laboratories at Columbia University. If funded, the renewal of this program will further engage a
diverse group of 100 students in rigorous and comprehensive training in authentic science practice over the
next five years, and we will continue to assess and report on the long-term outcomes of a successful summer
research program designed to increase diversity in the scientific workforce.
The program provides a diverse group of high school students from underprivileged communities with the
necessary support to develop their sense of identity and self-efficacy in science, technology, engineering, and
math (STEM). We propose to continue recruiting students through partnerships with current youth-serving
programs in the communities via an inclusive application process. We aim to increase students’ scientific
knowledge, confidence, and preparation for college and careers in STEM through directed training, mentoring,
and research experience with a focus on neuroscience. We will achieve this via the two main parts of the
program: (1) A comprehensive training program during the spring that incorporates parental involvement,
training on neuroscience content and lab skills, critical thinking and communication skills, and student-mentor
matching assistance. (2) Summer laboratory experiences combined with weekly advisory sessions, training for
research mentors, a final poster presentation, field trips, and opportunities to network with program alumni.
We have also identified new initiatives to strengthen the program to be carried out during the renewal period.
We aim to deepen our support of our participants’ career development and college applications in STEM fields
through consistent near-peer mentoring that will provide personalized guidance, foster academic and
professional growth, and cultivate a supportive community of individuals with shared experiences and
aspirations. We will also continue to develop opportunities for program alumni to engage with current students
and scientists, and participate in follow-on research. We will follow an iterative approach to the neuroscience
curriculum based on student feedback, and track our success using a mixed-methods evaluation plan. We will
further develop alumni engagement, building additional research, teaching, and career development
opportunities for alumni. In this way, we will reinforce our participants’ intent to pursue studies or careers in
STEM, which we will track before and after the program, and over time via focus groups and alumni surveys.

Public health relevance
PROJECT NARRATIVE The Brain Research Apprenticeships In New York At Columbia (BRAINYAC) program addresses science education disparities found in low-income neighborhoods by providing an authentic mentored research experience for a diverse group of high school students from low-income neighborhoods. We provide hands-on research experience in neuroscience laboratories, preparatory training, and continued opportunities after the program ends. Our goal is to support students’ intent to pursue studies or careers in science, technology, engineering, and math (STEM) through increasing students’ sense of identity and self-efficacy in STEM.